Mechanisms of neurovascular coupling in the retina and their dysfunction in diabetes

Project Summary
One of the defining features of blood circulation in the central nervous system is its capacity to be regulated by
signaling from neurons and glia. In the retina, this feature, termed neurovascular coupling (NVC), occurs on the
level of larger arterioles down to individual capillaries. Dilation and constriction of these capillaries is controlled
by vasoactive cells called pericytes. The retinal vasculature is organized in an expansive network of three
laminae which supply nutrients to distinct types of neurons organized in corresponding layers. Previous work
has shown that flow through each lamina is differentially regulated by light, but the mechanisms of NVC in the
retina and how they could differ between laminae remain poorly understood.
Revealing the mechanisms of NVC in the retina is an important public health concern because there is a
growing body of evidence that NVC dysfunction is critical to the pathology of diabetic retinopathy, a blinding
disease affecting 35% of patients with diabetes. Treatments for diabetic retinopathy are targeted towards late-
stage vascular complications, but there are no current treatments targeted towards NVC dysfunction.
This project seeks to determine the underlying parameters of light stimulus that lead to vasoactivity in the
retina and the cellular mechanisms that make this possible. I will use electrophysiology and two-photon
imaging to measure pericyte activity and capillary diameter in the ex vivo mouse retina, and I will develop a
computational model of blood flow and nutrient diffusion throughout the retina. I will also explore the role of
hyperglycemia in the NVC dysfunction seen in diabetes. Successful completion of this project will lead to a
better understanding of how blood flow in the central nervous system is regulated, potential targets for therapy,
and the establishment of a model system for future explorations of how the nervous and circulatory systems
are intertwined.

Public health relevance
Project Narrative Diabetic retinopathy is a vision-reducing disease that impacts 35% of patients with diabetes, and up to 150 million people worldwide are expected to be affected by 2030. Diabetic retinopathy is believed to occur due to changes caused by sugar in two systems within the retina: blood vessels and light-sensing neurons. This project will investigate the mechanisms of how abnormal interaction of these systems contributes to disease.